PET Imaging of Damaging Neuroinflammation in Alzheimer's Disease Technical and Business Assistance (TABA)

Alzheimer’s disease (AD) is a devastating and progressive disease without a cure. Neuroinflammation is now
recognized as a key early event in the development of AD. A non-invasive imaging method to detect and
assess early damaging neuroinflammation would be able to detect disease before irreversible damage occurs.
We at Einsenca are developing a PET imaging method to detect and monitor oxidative stress and consequent
damaging neuroinflammation in AD. Intellectual property protections will be critical to future commercialization
and ultimate clinical translation of these PET imaging methods. We request administrative supplement support
for technical assistance with these intellectual property protections. Currently Einsenca possesses limited
rights for development and validation of these PET imaging technologies that originated at academic partner
Massachusetts General Hospital (MGH). TABA support will be used to fund ahighly experienced attorney from
a full-service national law firm (Potomac Law Group) to evaluate the strength, validity, and enforceable nature
of the patents intended to be exclusively licensed by Einsenca along with anticipated freedom to operate and
commercialize the technology. Potomac Law Group will also assist Einsenca in the financial valuation of the
technology and draft, negotiate and conclude the definitive exclusive license agreement between Einsenca and
MGH. Finally, Potomac Law Group will draft templates and assist in negotiation of sponsored research,
materials transfer, and confidentiality agreements important for development work with both commercial and
academic partners.

Public health relevance
Aberrant oxidative neuroinflammation is a key early event in the development of Alzheimer’s disease (AD). We are developing a noninvasive positron emission tomography (PET) imaging method to quantify and monitor myeloperoxidase-mediated oxidative stress in the AD brain. Technical assistance with intellectual property protections will be critical for commercialization of these innovative PET imaging methods.